ROLE OF ESTROGEN ON URINARY INCONTINENCE AND SYMPTOMS IN POST-MENOPAUSAL WOMEN

Incontinence and urinary symptoms of frequency and urgency are prevalent in post-menopausal women. This project is designed to evaluate the effectiveness of topical estrogen in the behavioral treatment of urinary symptoms and incontinence.